NCRR BOOTH AT SUPERCOMPUTING CONFERENCE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Supercomputing Conference brings representatives from a variety of leading edge technical development areas together to report progress, exchange information and establish new collaborations. The presence of NCRR funded centers and projects would enhance the visibility and impact of the research activities, and software products for the benefits of the communities. NBCR sponsors the production of a NCRR brochure with information about all the NCRR biomedical technology division projects, as well as a poster on each project for display during the conference. A series of talks and demonstrations are also contributed by various participating centers and projects.